Identity and Neural Encoding of Social Odors

ABSTRACT
Mammals use pheromones to find mates, regulate reproduction, and organize social behavior. The
identification of new pheromones, purified from natural sources, has repeatedly triggered new discoveries
about the genes, cells, and circuits essential for social behavior.
Recently, my lab identified two novel pheromones present in male mouse urine. These pheromones
play an essential role in at least one behavior, the acceleration of puberty in juvenile females. However, several
features of these new pheromones, and the responses of the neurons that detect them, suggest an even wider
role. Structural clues present in these new compounds hint at a previously-unsuspected mechanism for their
detection involving multiple sensory systems, receptor genes, circuit mechanisms, and metabolic pathways.
We propose to (1) determine whether a multisensory complex involving both volatile and nonvolatile cues
coordinate the discovery, detection, and recognition of these vital cues, (2) identify the receptor genes involved
in their detection and consequent behaviors, and (3) test whether stereotyped circuit features contribute to the
production and plasticity of suitable behavioral responses. We believe that the new opportunities afforded by
these novel pheromones will provide new tools to probe fundamental mechanisms regulating mammalian
physiology and behavior.

Public health relevance
PROJECT NARRATIVE Sexual maturation and reproduction are regulated by environmental cues, but the precise nature of these cues remains largely unknown. We discovered two novel pheromones that trigger early puberty in female mice. This proposal analyzes the genetic and neural-circuit mechanisms used to detect and respond to these external cues.